RANDOMIZED PROSPECTIVE TRIAL COMPARING CERVICAL CERCLAGE

Corticosteroids are routinely administered to mothers at risk for preterm delivery, for fetal indications, on a weekly basis. Exogenous corticosteroid administration may cause secondary adrenal insufficiency, which can lead to life threatening metabolic complications in times of stress from surgery, labor and delivery, hemorrhage, hypotension, or infection. Adrenal insufficiency in times of stress can be prevented by the administration of stress dose steroids. The physiological effects of antenatal steroid administration on the maternal adrenal gland has not been studied. Pregnant women who have received multiple doses of antenatal steroids currently do not receive stress dose steroids in times of stress. The adrenocorticotropin hormone (ACTH) stimulation test assesses the adrenal gland's ability to produce cortisol and is used to diagnose adrenal insufficiency. This study proposes to perform the ACTH stimulation test on pregnant women who have received greater than one dose of antenatal corticosteroids for fetal indications to ascertain whether these women are at risk for adrenal insufficiency in times of stress.